Mechanisms of SGLT2 Inhibition in Pediatric NAFLD

Project Summary / Abstract
Nonalcoholic fatty liver disease (NAFLD), characterized by excessive deposition of fat in the liver, is the most
common pediatric liver disease (~13% prevalence among 2-19 years old) and is exacerbated by obesity and
insulin resistance. Presently, there are no treatment options for pediatric NAFLD that produce meaningful and
durable hepatic fat reductions. Pharmacotherapy may be able to close the tremendous gap in clinical care.
Sodium glucose co-transporter-2 inhibitors (SGLT2i) represent an attractive and potentially effective treatment
option for NAFLD with supportive data in adults and animal models but has yet to be examined in pediatrics. In
adults with type 2 diabetes and obesity, SGLT2i medications reduce body weight, improve insulin sensitivity, and
decrease hepatic fat. Unlike adults, the vast majority of adolescents with obesity and NAFLD are insulin resistant
but have yet to develop type 2 diabetes. Thus, the pediatric population is ideal to test the first central hypothesis
that SGLT2i therapy drives reductions of hepatic fat in the absence of diabetes. SGLT2i paradoxically increases
fasting endogenous glucose production (EGP), which is not commonly encountered with other insulin sensitization
medications. Therefore, the second central hypothesis is that SGLT2i augments hepatic mitochondrial fatty acid
beta-oxidation, producing the acetyl-CoA that stimulates gluconeogenesis-derived EGP in a pediatric, non-
diabetic population. The collaborative transdisciplinary team is uniquely positioned to leverage a randomized,
controlled trial to test whether the SGLT2i empagliflozin may be a successful treatment for pediatric NAFLD. A
focused, mechanistic clinical trial will be performed studying older adolescents (ages 16-≤20 years; n=40) with
MRI-determined NAFLD (hepatic fat ≥5.5%) and obesity (BMI ≥30kg/m2) without T2D, to examine the response
to 10mg, once-daily oral dose of empagliflozin for 26-weeks to identify mechanisms of action and initial efficacy
of the SGLT2i agent empagliflozin as a treatment for pediatric NAFLD, through the following Specific Aims: (1)
Use SGLT2i treatment to quantify the dynamic relationship between hepatic fat content and insulin sensitivity in
an adolescent population. Gold-standard 2-stage hyperinsulinemic-euglycemic clamps and MRI-determined
NAFLD will be used to determine whether SGLT2i driven reductions in hepatic fat are associated with the degree
of improvement in both hepatic and peripheral insulin sensitivity. (2) To determine the mechanisms through which
SGLT2 inhibition decreases hepatic fat content. Non-invasively delivered dual stable isotope tracers and magnetic
resonance spectroscopy-based methods will be used to quantify adipose tissue lipolysis, hepatic fat oxidation
(both terminal oxidation and ketogenesis), and the gluconeogenic and glycogenolytic components of EGP, to
determine whether the degree of hepatic fat reduction correlates with the degree to which SGLT2i drives hepatic
fat oxidation. This study represents a novel and innovative investigation into a promising medical therapy for a
highly prevalent disease in the pediatric population, which currently has limited treatment options.

Public health relevance
Public Health Relevance This study will examine the effect of a novel treatment for treating non-alcoholic fatty liver disease among adolescents with obesity. Furthermore, we will examine the mechanism by which this treatment changes insulin sensitivity, glycemic control, and liver fat content. If successful, this trial represents a first step toward a clinically relevant treatment of pediatric non-alcoholic fatty liver disease and a greater understanding of how empagliflozin works.